Administrative Core

Project Summary: Administrative Core
This BRAIN Initiative proposal Oxytocin Modulation of Neural Circuit Function and Behavior is located at NYU
Grossman School of Medicine, and each of the four Project team labs (Tsien, Buzsaki, Lin, and Froemke) are
housed within the Neuroscience Institute at NYU Langone Health, in proximity to the five Cores (Administrative,
Behavior, Computational Modeling, Data Science, and Molecular Tools). The first five years of this effort was
considerably productive and transformative here at NYU, leading to a number of collaborative publications and
set the groundwork for this new proposal. Our team studies and activites will therefore benefit from integration
with the larger NYU scientific environment, including the Neuroscience graduate program, an existing and robust
scientific outreach program, a strong history of activities supporting diversity and inclusion, and institutional
resources including a cutting-edge health science library and data management system and a strong
administrative staff.
This Administrative Core will help ensure the management, coordination, and interactions between these
components of this proposal. Aim 1 of the Administrative Core is to continue to enable productive and synergistic
interactions between Project team labs, coordinating with the Internal and External Advisory Committees, and
scheduling regular meetings for open communication, sharing of scientific results, developing collaborations,
and providing opportunities for trainee engagement. Aim 2, under the direction of Dr. Froemke as mentorship
and diversity champion, is to enhance the scientific training and careers of junior colleagues in team labs,
including graduate students, postdoctoral fellows, and technicians, by facilitating co-advising and interactions
with NYU training programs. We will also develop activities that support diversity, equity, and inclusion efforts for
trainees and staff with under-represented minority backgrounds. Aim 3 is to ensure that our results are clearly
communicated in a timely manner to NIH staff, other scientists, and the public. Our labs are committed to data
sharing, and we will continue to work with the Data Science Core on these efforts. The Neuroscience Outreach
Group at NYU has substantial connections with schools and museums throughout New York City, and engages
in activities both at the city and national level (particularly through the Society for Neuroscience). Finally, Aim 4
will ensure the appropriate management of Project and Core finances and the overall budget. Administrative
Core Co-Directors and staff members are highly experienced at managing multi-PI projects and budgets. Drs.
Tsien, McKellar, and Froemke, bring complimentary expertise and a solid working relationship to their leadership
roles within the Administrative Core. They will continue to enable synergistic and accelerated scientific progress
across team labs, support career development of trainees and foster a community that is diverse and inclusive,
and effectively communicate our findings to the greater scientific and public communities.